The impact of cochlear synaptopahty on brainstem mechanisms of monaural temporal processing and binaural hearing

PROJECT SUMMARY
Binaural hearing allows localization of sounds and confers advantages in complex environments, workplaces,
classrooms, etc., where competing speech, noise, and reverberation abound. Unfortunately, an increasing
population, spanning infancy through elderly and of diverse etiology, experiences difficulty in such
environments despite having normal audiometric thresholds. Such difficulties are a hallmark of auditory
processing disorders, or listening difficulties (LDs), which refers to difficulties in processing sound in the central
auditory system as demonstrated by poor performance, often specifically in binaural hearing tasks. LDs can
emerge from noise exposure, temporary hearing loss, aging, autism, and neurodegenerative diseases. The
consequences of LDs can be severe; in children, LDs impact speech and language learning and academic
performance and in adults, quality of life, job performance, fitness for duty, etc. Regardless of etiology, a
limitation in LDs is that clinical diagnosis is based on a cluster of symptoms, many of which overlap with other
disorders such as attention deficit disorder, learning disabilities and language deficits. An additional barrier to
diagnosis and development of future treatments to alleviate LDs is that neither the neural mechanisms nor the
loci in the auditory system that produce these LDs are yet fully understood. We hypothesize that many LDs are
attributable to reductions in peripheral temporal coding that in turn impact binaural processing at the brainstem
level. We think binaural hearing is essentially ‘a canary in the coal mine’ for LDs that aren’t associated with
audiologically-diagnosed hearing loss. Here we test the hypothesis that two hearing deficits, namely cochlear
synaptopathy and extended high frequency hearing loss (EHFL), can cause LDs. The LDs resulting from these
deficits are often called “hidden hearing loss” because the hearing impairment is typically hidden from standard
audiological assessments. To better identify and treat subjects with such LDs requires understanding the
mechanisms that lead to and therefore predict LDs. In this proposal, we hypothesize that noise-induced
cochlear synaptopathy causes reduced monaural peripheral temporal coding leading to impaired binaural
brainstem function and deficient binaural hearing abilities. The underlying contributions of synaptopathy to LDs
are unclear, and there may be confounding/coexisting factors occurring following noise exposure. One
suspected factor is loss of hair cells in extended high frequency regions of the cochlea, resulting in EHFL.
Therefore, we also study the joint impact of synaptopathy and EHFL. Finally, based on preliminary data we
explore the hypothesis that synaptopathy leads to activity-dependent demyelination, due to persistently
reduced neural activity, in the brainstem circuits that support initial binaural processing. Because myelin is
essential for the precise encoding of temporal information, we hypothesize that even subtle changes in myelin
in these circuits can impair binaural processing and thus monaural temporal and binaural hearing ability.

Public health relevance
PROJECT NARRATIVE An ever increasing population, spanning infancy through the elderly and of diverse etiology - despite having normal audiometric thresholds - experiences severe difficulty in aurally communicating in complex environments such as workplaces, classrooms, and restaurants where competing speech streams, noisy backgrounds, and reverberation abound. A major challenge is how to identify and treat such individuals as current clinical diagnosis is based on a cluster of symptoms, many of which overlap with other developmental disorders such as attention deficit hyperactivity disorder, learning disabilities and language deficits. In this proposal we investigate the impact of noise exposure on brainstem mechanisms of binaural hearing.